Novel AI-Enabled Wearable Sensor for Scratch Monitoring

Project Summary
Itch is a distressing and highly prevalent symptom across a wide range of dermatological and systemic
diseases, profoundly impacting quality of life, particularly through sleep disturbance and skin damage. In atopic
dermatitis (AD), itch is the hallmark symptom and drives both disease burden and therapeutic response.
However, the current standard for measuring itch relies heavily on patient-reported outcomes (PROs), which
suffer from limited reliability, especially in pediatric populations and during unconscious periods such as sleep.
Scratching is the primary behavioral response to itch and offers a unique, objective, and quantifiable proxy for
itch severity. Our team has developed and iteratively refined a novel, hand-mounted wearable device (ADAM)
that uses both acoustic and motion sensors to detect scratching behavior with high temporal resolution. In
2021, the FDA accepted our COA Letter of Intent which allowed us to develop, validate, and clinically test the
initial version of ADAM. We demonstrated high AI classification accuracy (99%), compliance with IEC 60601
safety standards, and achieved key milestones including battery life extension and cybersecurity
improvements. In this proposal, we aim to respond to recent FDA feedback and finalize qualification of the
updated ADAM sensor towards full qualification. In Aim 1, we will validate scratch intensity by comparing
AI-generated outputs against force plate measurements under controlled conditions. In Aim 2, we will develop
and validate new algorithms for estimating body surface area (BSA) scratched and body location of scratching
using supervised videography. In Aim 3, we will conduct a 1-week clinical validation in 30 pediatric and adult
AD patients using infrared nighttime videography and daily diaries as gold standards. This work will close the
gap between subjective PROs and objective behavioral biomarkers of itch, fulfilling a critical need in
dermatology and drug development. Our validated digital endpoint will directly support regulatory-grade
applications in AD and form the foundation for broader deployment in other pruritic disorders. The proposed
research aligns with the FDA’s Clinical Outcome Assessment Qualification Program and the NIH’s interest in
advancing digital health technologies for real-world patient monitoring.

Public health relevance
Project Narrative This project aims to validate a novel hand-mounted wearable sensor (ADAM) for quantifying scratching as an objective measure of itch in patients with atopic dermatitis (AD). We develop and validate algorithms for scratch intensity, body surface area scratched, and body location using AI algorithms benchmarked against force plates and IR videography. Results will support full FDA qualification and enable broader applications for pruritic conditions beyond AD.